Diversity supplement for noninvasive, wireless thermal sensors for the quantitative monitoring of ventricular shunt function in patients with hydrocephalus

ABSTRACT
Hydrocephalus is a neurological disorder caused by buildup of excess cerebrospinal
fluid (CSF) in the brain, and leads to lethargy, seizures, coma, or death. It is treated with the
surgical implantation of a catheter, known as a ventricular shunt, that diverts excess CSF away
from the brain and into a distal absorptive site, such as the abdomen. Unfortunately, due to
occlusion or mispositioning, shunts have extremely high failure rates - 51% in 2 years, and 98%
over 10 years - and often require corrective surgical procedures, known as revisions. 125,000
shunt implantations or revisions are performed annually in the United States, at a cost of $2
billion.
Diagnosing shunt failure is extremely difficult, due the non-specific nature of its
symptoms. Imaging tests such as CT are commonly used despite their long-term radiation
exposure risks and invasive tests such as CSF aspiration and radionuclide tracing are painful
and carry significant infection risks. All the above tests have poor diagnostic performance, with
low sensitivities (~80%) and specificities (~55%), in large part because they do not directly
measure flow dynamics, arguably the most important and relevant shunt performance metric.
The continuous, non-invasive, real-time monitoring of CSF flow through implanted
shunts represents a critical unmet need. Clinicians would use these data for point-of-care
diagnostics, and researchers would use them to better understand shunt failure, and elucidate
the pathophysiology of poorly-understood conditions such as normal-pressure hydrocephalus.
The present proposal addresses this need by capitalizing on existing wireless sensor hardware
to develop the first skin mounted wireless product to give quantitative CSF flow data in
implanted shunts. Using precise measurements of thermal transport, we will develop novel
algorithms to characterize and quantify flow through underlying shunts with high accuracy.
Preliminary patient data, benchtop tests, and computer modeling confirm the ability of the
sensor to produce high-quality flow data while being mechanically unobtrusive to the patient.
Phase I activities will validate the sensor on large animal models, develop algorithms to
deliver quantitative flow data, and implement a quality management system to govern software
development, ultimately leading to IRB approval for clinical testing. Phase II activities will
validate diagnostic value of the sensor’s performance clinically through a human trial, ultimately
leading to a marketing submission to the FDA.

Public health relevance
Rhaeos will commercialize a non-invasive, soft, wearable, wireless sensor that will provide real- time information about CSF flow through implanted ventricular shunts in hydrocephalus patients. This technology will obviate the need for expensive and often inconclusive testing for shunt failure, and minimize concerns about long-term radiation exposure, while also allowing researchers a tool to further study the condition. The sensor will be validated on animal models during phase I and human trials during phase II of the proposed program.